TO# 2018-02; NExT Z-Endoxifen CT025-402-448-004 - API Batch analysis Milestone 4, Analysis of Anti-Cancer Chemical & Pharmaceutical Formulations, HHSN261201700011I, DTP-18-022, 5/15 - 8/15/18,

The analysis of bulk drug lots to be used in clinical trial, according to FDA regulations.